SMAD MEDIATED SIGNALING DURING LUNG MORPHOGENESIS

Studies of the molecular embryology of the lung are likely to provide significant new understanding of the molecular mechanisms of lung development, injury and disease. We have demonstrated that TGF-beta receptor-mediated autocrine/paracrine signaling negatively regulates early lung development. The recent identification of the Smad family signal transducer proteins has unraveled new mechanisms by which TGF-beta signals from the cell membrane to the nucleus, and our preliminary data show that Smad-mediated signaling modulates mouse lung branching morphogenesis and cytodifferentiation. Hypothesis: Specific Smad gene expression regulates TGF-beta signaling, and thus instructs early mouse embryonic lung branching morphogenesis. Specific Aims: Aim 1. To define the developmental and temporo-spatial expression of Smad genes during embryonic lung development (i) in vivo and (ii) in lung explant culture. Aim 2. To determine the molecular mechanism of TGF-beta pathway- restricted Smad2 and Smad3 in regulating embryonic pulmonary branching morphogenesis and cytodifferentiation in serumless culture using both (i) "loss-of-function" and (ii) "gain-of- function" strategies. Aim 3. To define the biological function of the feedback inhibitory Smad6 and Smad7 proteins during embryonic lung branching morphogenesis in culture. (i) Time- and dose-dependent TGF-beta-induced inhibitory Smad6 and Smad7 gene expression patterns will be delineated in lung explant culture. (ii) The antagonistic mechanism by inhibitory Smad6 and Smad7 on TGF-beta signaling during lung development will be determined in embryonic lung culture. Novel molecular mechanisms to control lung morphogenesis and significance to human health: The current proposal will define novel molecular mechanisms in which Smad-mediated signaling regulates embryonic lung branching morphogenesis. The results of this project will provide new rationales for novel therapeutic strategies to modulate TGF-beta signaling during lung development, injury, repair, and disease.